Targeting Escherichia coli PBP1b using fragment-based approaches

Penicillin-binding proteins (PBPs) are proven β-lactam drug targets yet resistance to β-lactam antibiotics,
such as carbapenems and cephalosporins, has resulted in a global health problem. In particular, extended-
spectrum β-lactamase (ESBL) producing or carbapenem-resistant Enterobacteriaceae, which includes
Escherichia coli, are serious threats and are often linked to hospital-acquired infections. Bloodstream
infections caused by these pathogens have a high mortality rate. β-lactam antimicrobial resistance
mechanism in E. coli are multiple and include, for example, the expression of β-lactamases that can degrade
β-lactams, deletion of porins, and the overexpression of efflux pumps. Resistance is developing even
against new β-lactam/β-lactamase inhibitor combinations. This alarming resistance spurs the need to
develop different mechanisms of PBP inhibition to break this resistance cycle.
PBP1b, one of the key PBPs in E. coli, has two peptidoglycan (PG)-related catalytic activities: a
transglycosylase activity and a transpeptidase activity. Both activities build the PG mesh that provides critical
mechanical strength and shape for bacteria. PBP1b is activated by LpoB binding to PBP1b, leading to a
conformational change that stimulates both activities of PBP1b. Our goal is to develop a novel approach to
inhibiting PBP1b, by targeting the activation of PBP1b by LpoB. Deletion of LpoB or mutations in LpoB
that disrupt PBP1b binding leads to hypersensitivity to certain β-lactam antibiotics.
Aim 1: We propose to develop inhibitors of PBP1b activation by screening and developing compounds
that bind to the PBP1b-recognition site on activator LpoB via a fragment-based structural approach. We will
use thermal shift and split luciferase complementation assays to screen fragment library compounds. Hits
from these orthogonal assays are further probed using dose-response measurements, biophysical tools,
and a TG activity assay testing for a decrease of LpoB-mediated activation of PBP1b.
Aim 2: Fragment hits will be targeted for crystallographic analysis in complex with LpoB. The combined
structural information, affinity, activity, and thermal shift data will be used to design novel LpoB-directed
inhibitors in an iterative fashion. Top lead compounds will advance to microbiological testing.
The successful completion of our comprehensive high-risk/high-reward PPI targeting approach will lead
to a new strategy of re-sensitizing PBP-targeting antibiotics, which is urgently needed in light of the
current antibiotic resistance problem. The LpoB:PBP1b system is conserved in Enterobacteriaceae so our
results could extend to other pathogens. Furthermore, the successful outcome of this proposal could lead
to a paradigm shift in antibiotic development, re-focusing efforts on targeting PPIs in bacterial pathogens.

Public health relevance
Penicillin-binding proteins (PBPs) are proven drug targets yet resistance to β-lactam antibiotics, such as carbapenems and cephalosporins, has resulted in a global health problem. We aim to overcome the resistance mechanisms and resensitize β-lactam antibiotics by developing inhibitors of the LpoB-mediated activation of PBP1b, a key PBP of Escherichia coli.